Personality and Mortality Risk in Adulthood: Behavioral and Physiological Mechanisms

Sufficient evidence now exists that individual differences in personality traits are associated with lifespan health
outcomes and longevity. Interests have shifted from these basic examinations of personality-health
associations to identifying the precise mechanisms explaining why psychological traits predict health and
longevity. Exploring how health behaviors and physiological function act as conduits by which personality
impacts health is the logical next step of future research. Specifically, individuals scoring higher in neuroticism
and lower in conscientiousness are more likely to use tobacco, illicit drugs, and greater quantities of alcohol,
and are also more likely to be sedentary and have poor dietary habits. These behaviors are some of the
leading behavioral contributors to poor health and increased mortality risk among older adults. Moreover, these
trait levels are also associated with increased cardiovascular deterioration, impaired immune function, and
unhealthy metabolic levels. Although it seems intuitive that individuals with certain personality characteristics
engage in certain behaviors which over time will deteriorate physiological health and shorten the lifespan, the
empirical evidence to support these explanatory pathways is lacking. Without a clearer understanding of how
these processes unfold over the lifespan, the development of interventions to combat premature aging will be
limited. Thus, the short-term goal of this proposal parallels NIA strategic directions to identify mechanisms
through which psychological factors exert their effects on the aging process, but it also parallels the NIA long-
term goal agenda of developing foundational knowledge to be used in the creation of interventions that
maintain health and increase a healthy lifespan. The central hypothesis of the current proposal is that certain
personality characteristics will lead to engagement in health behaviors (e.g., greater alcohol, tobacco, drug
use, physical inactivity, lower health care utilization, and poor sleep habits) that will lead to dysregulation of key
physiological systems, that ultimately will result in an increased mortality risk. To accomplish these goals, the
proposal will utilize a coordinated analysis framework to analyze 12 archival data sources that include over
44,000 participants. Key factors to this proposal include: 1) a diverse population where generalizability of
findings can be tested via replication and meta-analytic techniques; 2) analysis of repeated measures of
personality, health behaviors, and objective measures of physiology to determine how change unfolds over
time and establish temporal ordering of pathways; and 3) the use of sophisticated mediation analyses
conducted in a structural equation modeling framework to provide the statistical evidence of direct/indirect
effects. Overall, the proposed research is significant because it explores how modifiable psychological
constructs impact behavior, physiology, and longevity over time. Understanding how these processes unfold in
a large sample using diverse measures will provide the statistical evidence needed to support the development
of interventions aimed at improving aging outcomes.

Public health relevance
Project Narrative With increasing life expectancy and the baby-boom generation reaching older age, it is necessary to identify mechanisms that either promote or impede healthy aging and eventually intervene to improve health. The proposed research is significant because by identifying the mechanisms connecting personality to mortality risk, a blueprint can be developed of how personality leads to mortality that will be needed when developing interventions to combat premature aging. Once such interventions are refined and implemented, there is the promise that by targeting root causes of unhealthy behaviors and physiological dysregulation—personality— there will be widespread improvements in physical health, well-being, and longevity.